EVA, AN EARLY VOCALIZATION ANALYZER

The goal of this project is to develop an Early Vocalization Analyzer (EVA), a computer program to automatically analyze recorded samples of infant vocalizations. This program will be the basis of a screening test, for use in hospitals and clinics, to evaluate which infants are at-risk for later communication or other developmental problems. The major purpose of this Phase-I project is to determine whether the landmark detection theory of Stevens, as implemented for the recognition of adult speech, can be adapted to the analysis of syllabic pre-speech vocalizations produced by typically developing infants. We will also merge this landmark- detection algorithm with a kernel version of EVA, developed by a team at Northeastern University, to produce a proof-of-concept prototype that will count the number of utterances, detect and count syllable-like vocalizations, and classify them according to fundamental frequency and duration. The goal of Phase II is to develop a commercial software program to automatically analyze infant utterances from audio recordings, as a non-invasive research and clinical-screening instrument. PROPOSED COMMERCIAL APPLICATIONS: The product would be useful for hospitals and infant-screening clinics assessing developmental risks, as well as hearing deficits. It could also be used by treatment centers to the efficacy of early intervention. Finally, it would provide a research tool for investigations of the earliest stages of infant speech and of age-specific control of the speech articulators.